Project 4: Pathologic Tau Strains Underlying FTLD-Tau Variants

PROJECT 4: Pathologic Tau Strains Underlying FTLD-Tau Variants Project Leader: John Q. Trojanowski; Co-Leader: Virginia M.-Y. Lee Project Summary/Abstract Dementia due to frontotemporal degeneration (FTD) is nearly as common as Alzheimer's disease (AD) in patients <65 of age. FTD results in frontotemporal lobar degeneration (FTLD) and ~95% of FTLD is due to tau (FTLD-Tau) or TDP-43 (FTLD-TDP) inclusions. FTLD-Tau and FTLD-TDP account for ~45% and ~50% of FTLD, respectively, and ~5% is due to FUS pathology (FTLD-FUS) or other rare forms of FTLD. However, 25% of clinical FTD is due to atypical AD. FTLD-Tau syndromes include progressive supranuclear palsy (PSP), corticobasal degeneration (CBD) and Pick's disease (PiD) and other more rare variants. Although the precise toxic species of pathological tau are unknown, the stereotypical progression of AD tau pathology suggested the spread of an unknown pathogen which was identified by demonstrating that extracts of different tauopathy brains injected into tau transgenic (Tg) mice induced distinct tauopathies. Indeed, the pathological features of the tau inclusions induced by extracts from PSP, CBD, PiD and AD brains correspond to the neuronal and glia tau pathology seen in each disorder. Thus, we hypothesize that tau pathology in CBD (CBD-Tau), PSP (PSP- Tau) and PiD (PiD-Tau) represent different strains of pathological tau that account for the clinical and pathological heterogeneity of FTD tauopathies. Further support for this has come from Projects 3 and 4 in this Program Project Grant (PPG) by demonstrating that pre-formed fibrils (PFFs) assembled from recombinant human tau were sufficient to induce tau pathology in tau Tg mice overexpressing mutant human (P301S) tau (PS19 line) and that injections of enriched CBD-Tau or AD-Tau into the brains of PS19 mice induced CBD-like or AD-like tau pathology. Moreover, the spread of tau pathology in tau PFF and AD-Tau injected PS19 mice followed the neuroanatomical connectome of the injection sites which differed from the spread of glial tau pathology induced by CBD-Tau. Finally, injections of AD-Tau and tau PFFs resulted in neuron loss, which was not seen in the CBD-Tau injected PS19 mice. Moreover, diverse manifestations of FTLD-Tau variants also could reflect the differential effects of genetic modifiers of tau pathology discovered by Project 2 in this PPG funding cycle. Taken together, these data support our hypothesis that CBD-Tau, PSP-Tau, PiD-Tau and AD- Tau represent different pathological tau strain that act in concert with genetic modifiers of tau pathology. Thus, Project 4 builds upon these remarkable new insights to test the hypothesis that distinct clinicopathological tauopathy variants are due to different strains of pathological tau in association with genetic modifiers of tau pathology in patient oriented studies to stage tau pathology in autopsy confirmed CBD, PSP and PiD as well as in experimental studies of CBD-Tau, PSP-Tau and PiD-Tau in a variety of mouse models including wildtype non-Tg mice, 6hTau Tg mice expressing only six human tau isoforms and the PS19 mice.

Public health relevance
PROJECT 4: Pathologic Tau Strains Underlying FTLD-Tau Variants Project Leader: John Q. Trojanowski; Co-Leader: Virginia M.-Y. Lee Project Narrative By testing the hypothesis that CBD, PSP and PiD are due to the emergence and spread of different pathological tau strains in association with genetic modifiers, Project 4 will elucidate mechanisms underlying the onset/progression of these disorders which could lead to better strategies to diagnose and treat these tauopathies.